Regulation of endothelial cell phosphatidylserine in thrombosis

Project Summary/Abstract
A prothrombotic vessel wall is implicated as a major driver of cardiovascular disease, including heart attacks,
strokes, and venous thromboembolism. Despite extensive research into the mechanisms of endothelial cell
dysfunction, the fundamental question of how a clot forms in blood vessels remains incompletely understood.
Activation of blood coagulation enzymes requires a membrane surface containing anionic phospholipids, most
notably phosphatidylserine (PS). PS-binding proteins decrease thrombosis in animal models suggesting that
targeting PS exposure may be a novel antithrombotic strategy. Plasma membrane PS is normally sequestered
on the inner membrane leaflet. To activate blood coagulation, PS must be externalized to the outside of the cell
by calcium-activated phospholipid scramblases. Platelets readily externalize PS in vitro, and it has often been
assumed, but not clearly demonstrated, that platelets generate the procoagulant PS to promote thrombosis in
vivo. Our data demonstrate that (1) the majority of PS externalization in vivo actually derives from the vessel
wall, independent of platelets, and (2) inhibiting TMEM16 phospholipid scramblases decreases the thrombotic
potential of the vessel wall. We have identified two TMEM16 family members, TMEM16F, and its closest
paralog TMEM16E, that are both required for PS externalization and procoagulant activity in endothelial cells.
TMEM16E is not found in platelets and previously has no known role in coagulation. The central hypothesis of
this application is that the endothelial cell membrane is the primary source of PS in forming a thrombus, and its
externalization is regulated by two scramblases, TMEM16E and TMEM16F. In Aim 1 we will determine the
mechanism by which both TMEM16E and TMEM16F promote PS externalization and procoagulant activity in
endothelial cells. In Aim 2 we will use mouse models and intravital microscopy to determine the contribution of
endothelial cell-derived PS to thrombosis and how it is regulated by TMEM16E and TMEM16F in vivo.
This proposal describes a five-year research training program for Dr. Alec Schmaier’s mentored career
development. The applicant has a strong research background in platelet activation from the Medical Scientist
Training Program at the University of Pennsylvania. This proposal expands his skill set through investigations
in endothelial cell biology, blood coagulation and vessel wall thrombosis. Dr. Robert Flaumenhaft in the
Division of Hemostasis and Thrombosis at Beth Israel Deaconess Medical Center will be the primary research
mentor. Dr. Flaumenhaft has a distinguished record of mentorship and innovation in thrombosis research. In
addition, the applicant’s advisory committee will provide highly relevant scientific expertise and critical
assessment of his progress. In sum, Dr. Schmaier has created an outstanding environment to advance his
research and career goals to be a physician-scientist in cardiovascular medicine. This comprehensive training
program will position him to succeed as an independent investigator in thrombosis and vascular biology.

Public health relevance
Project Narrative Phosphatidylserine is a lipid whose exposure to blood promotes clotting. This proposal uses animal models and state-of-the-art microscopy techniques to study how endothelial cells on the blood vessel wall contribute phosphatidylserine to generate thrombosis. By studying the regulation of phosphatidylserine exposure on endothelial cells, we will gain a better understanding of how blood clots form in vessels, which may allow for the development of novel therapeutics to treat thrombotic disease.